CORE--GENERAL LABORATORY FACILITY

The general Laboratory Facility core will breed and maintain mice in the Specific Pathogen Free Mouse Colony for in vivo experiments, manufacture radiation devices and perform dosimetry for all proposed experiments, maintain radiation equipment used, prepare media and reagents for in vitro studies, prepare routine H&E stained slides for histologic evaluation, and wash and sterilize glassware and laundry.